Pacific Northwest Center for Translational Environmental Health Research

This project will develop and validate a survey tool designed to characterize scientist and public
perceptions around the use and dissemination of results from public use datasets to build
capacity in bioethics. Specifically, prior work by the Community Engagement Core of the Oregon
State University Pacific Northwest Center for Translational Environmental Health Research has
identified ethical considerations related to research resulting from public-use datasets. Unlike
individual studies, wherein there is often an ethical obligation to report-back research results
(RBRR) to study participants, there has not been an analysis of the ethical considerations nor
guidance concerning the return of aggregate results gleaned from public-use datasets. Using
feedback from content experts and stakeholders representing community groups,
environmental justice organizations, environmental health organizations and community-
engaged specialists, we will develop a survey tool to characterize scientist and public perceptions
around the use and dissemination of results from public use datasets. The survey tool will
additionally request feedback on adapting FAIR principles (Findable, Accessible, Interoperable,
Reusable) to the return of aggregate data obtained from public-use data, as a way of increasing
public understanding of research findings. The survey tool will be validated amongst a
population of interdisciplinary scientists and the public. The survey tool, associated data
dictionary, and validation results will be publicly available via OPEN ICSPR. The development
of this survey tool will enable future research, wherein a large, diverse population of scientists
and the public can be surveyed, and the resultant data will help guide oversight bodies and users
of publicly available data about whether the inclusion of a RBRR strategy should be required.

Public health relevance
As data becomes increasingly accessible, it is important to understand the ethical considerations that may arise to ensure that those who contribute data to the research also benefit from the knowledge gleaned from the data. This project will develop capacity in bioethics by developing a survey tool designed to capture different perceptions amongst scientists and researchers of how public use data is used and reported back. Data from this survey will ultimately inform future considerations regarding report-back of research results from public-use datasets.